PIT-1 GENE AND GH PROMOTOR MUTATIONS

Although this protocol is approved for admission of subjects, none are admitted for this reporting period. It utilizes the Molecular Cell Biology Laboratory only. The Lab Supervisor transforms and stores immortal Epstein-Barr virus lymphoblast cell lines from patient samples sent directly to the Lab. The cell lines then serve as a permanent DNA/RNA resource, as well as an in vitro model system for the molecular genetics investigations.